Development of a Personalized Voxel-wise Prediction of Brain Metastases using Multi-Parametric MR Imaging to Reduce Treatment Toxicity

Abstract:
Brain metastases (BM) present a significant therapeutic dilemma, particularly in patients diagnosed with non-
small cell lung cancer (NSCLC) adenocarcinoma who are at high risk of development of BM but where advances
in systemic and immunotherapies have significantly improved the 3-year survival rates with a resultant evolution
in therapeutic goals. For those with ≤4 BM, focal stereotactic radiosurgery (SRS) is standard but those with
greater burden of BM are indicated for whole-brain RT (WBRT). SRS has the advantage of minimizing dose to
macroscopically BM-uninvolved regions of the brain. However, the latent effectiveness of SRS remains unclear
as it may miss micro-metastatic disease undetectable by current MR imaging, evident in post-SRS progression
in untreated areas. WBRT achieves comprehensive BM control but may represent over-treatment of healthy
brain tissue, resulting in 65-80% cognitive failure rate. A key observation is the uneven BM risks across brain
regions, particularly at the white-grey matter junctions, thought to be in high perfusion areas near the blood-
brain-barrier. Recognizing this, our research's main goal is to devise and validate a tailored BM radiotherapy
that addresses at-risk areas while minimizing dose to unaffected regions of low risk. The initial goal seeks to
integrate four unique components: population-based, anatomical, vascular, and patient BM history, to formulate
a time-based patient-specific voxel-wise risk model. Drawing from a multi-centric database of 1,139 NSCLC
adenocarcinoma patients and 4,627 lesions, this model predicts areas with a higher propensity for BM. The
subsequent goal is to assess the potential dosimetric implications of these BM risk maps on individualized
WBRT. We anticipate that incorporating our BM risk predictions will achieve dose reductions ranging from 20-
100% for critical functional sub-structures with no more than 5% global risk of BM misses, a promising step in
addressing the pressing issue of WBRT-associated neurotoxicity. Through radiation simulations on retrospective
patients, our innovative "WBRT-PROTECT" (WBRT: Personalized Radiation Optimization To Eliminate
Collateral Toxicity) method will be juxtaposed against standard treatments to elucidate potential dose
optimization. The final goal focuses on clinical validation. Preliminary data suggests that our BM risk maps could
inform significant mitigation of brain radiation doses compared to conventional methods, through a modified
WBRT approach, enhancing neurocognitive and survival outcomes. To this end, our dual-pronged approach
comprises an in silico non-intervention trial across three institutions, matched with a single-center phase I
WBRT-PROTECT clinical trial. Notably, the design and endpoints of this clinical trial follow the neurocognitive
evaluations and intricate analyses exemplified in NRG CC001, the recently published landmark trial supporting
de-intensification of WBRT. Through these evaluations, our research not only pioneers a revolutionary treatment
strategy for patients with BM but also deepens our comprehension of the intricate mechanisms behind BM,
paving the way for future innovations in BM imaging, detection, segmentation, and therapeutic strategies.

Public health relevance
Narrative: The objectives of this R01 application are to: 1) create a timed personalized, voxel-wise risk model to predict brain metastases (BM) formation using extensive historical longitudinal data and four distinctive components (population modeled BM risk map, patient-specific anatomy and brain perfusion imaging, and individualized patient BM historical medical data); 2) quantify the dosimetric advantages of personalized BM risk maps for directed BM radiation treatment planning for non-small cell lung cancer (NSCLC) adenocarcinoma patients to potentially reduce radiation toxicities; and 3) test the feasibility and efficacy of our innovative WBRT-PROTECT (WBRT: Personalized Radiation Optimization To Eliminate Collateral Toxicity) approach in prospective clinical trials across multiple institutions. This research promises a transformative shift in managing BM, specifically for NSCLC adenocarcinoma patients, by offering tailored timed treatments that curtail WBRT side effects. Successful outcomes will pave the way for larger trials, coupled with significant advancements in BM detection, imaging, and the formulation of novel therapeutic strategies, ultimately improving both patient quality of life and survival.